TREATMENT OF OSTEOPOROSIS WITH DICLOFENAC SODIUM

Studies in laboratory animals suggest that prostaglandins mediate ongoing bone resorption and that estrogen inhibits prostaglandin synthesis. An investigation was begun to test the hypothesis that diclofenac sodium, a nonsteroidal anti-inflammatory drug, would be useful in preventing postmenopausal bone loss. Results in premenopausal women indicate that the drug produced a 20% decrease in urinary calcium and in postmenopausal women a 40% decrease in urinary calcium.